Capacity development among academic trainees to develop sustainment strategies in community settings

SUMMARY This Administrative Supplement to R01HL15838 (Enhancing capacity in faith-based organizations
to implement and sustain multilevel innovations to improve physical activity) is in response to NOT-OD-23-002,
the Notice of Special Interest (NOSI): Administrative Supplements to Recognize Excellence in Diversity,
Equity, Inclusion, and Accessibility (DEIA) Mentorship. Research demonstrates that most health programs are
not sustained beyond one year following initial implementation. Studies also shows that one of the most
important factors impacting students’ long-term and short-term goal achievement is effective mentorship at
diverse levels throughout their training. The proposed Administrative Supplement aims to enhance the
sustainment plan of Faith in Action, an evidence-based intervention (EBI) for increasing physical activity
among Latinas in church settings, through the implementation of three sustainment strategies (audit and
feedback loops, developing and establishing financial models, and increasing organizational capacity to
support sustainment). It is hypothesized that the three additional sustainment strategies in the Administrative
Supplement will optimize sustainment in the parent grant, allowing churches to continue receiving the benefits
beyond research grant funding. We will conduct structured nterviews with church leaders, church staff, and
promotoras (i.e., Community Health Workers) and brief SPRINT interviews with payers and experts. Findings
from these interviews will inform the development of an Action Plan for sustainment. The Administrative
Supplement also proposes to foster D&I and sustainment research skills of trainees from under-represented
backgrounds using rigorous methods (i.e., Intervention Mapping). This opportunity will also increase the
capacity of the team to develop a sustainable mentorship infrastructure that contributes to sustainment
research.

Public health relevance
Narrative This application for an Administrative Supplement to R01HL158538 in response to NOT-OD-23-002 will provide an opportunity to strengthen the mentoring infrastructure of the team. Outcomes are expected to help increase the pipeline of new scientists in biomedical research aimed to improve health outcomes of under-served communities.